Integrated metabolomic and microbial community analysis of estuarine sediments and their potential as sources of bioactive natural products

ABSTRACT
Estuaries are dynamic environments in which the variability of abiotic and biotic factors support highly diverse
microbial communities in sediments, including seagrass rhizospheres. A high likelihood of chemically mediated
interactions in these complex, competitive communities makes estuaries an exciting potential source of new
biologically active compounds. New pharmaceuticals are needed to combat drug resistance in the treatment of
infectious and chronic diseases. Compounds targeting the protein secretory pathway at the endoplasmic
reticulum (ER) display potent anticancer, antiviral, and antibacterial activities. Within this Sec61 translocon -
mediated pathway, protein chaperone GRP78 is emerging as a potential druggable target with inhibitors showing
efficacy against drug resistant cancers and viral and bacterial infection. Environmental sampling of sediments
provides access to metabolites from complex microbial communities, for investigating both their role in the
environment and potential biomedical relevance. Solid phase adsorbent resin samplers have been used
extensively to monitor toxins from harmful algal blooms and have recently begun to be applied to the detection
of natural products in marine sediments. The central hypothesis of this project is that microbial communities in
estuarine sediments are valuable sources of novel bioactive NPs, with potential for the treatment and
management of human disease, that may be accessed by in situ environmental sampling using adsorption
resins. Sediments in eelgrass beds and nearby unvegetated areas across an estuarine gradient in Oregon will
be sampled both by deploying adsorbent resin samplers and collecting small sediment scoops (Aim 1). The
adsorbent resin samplers facilitate direct sampling of sediment metabolites from the environment for chemical
and biological characterization. The sediment scoops enable parallel 16S rRNA microbial community analysis
and comparison of metabolites obtained by solvent extraction of sediment versus adsorbent resin. High
resolution LC-MS/MS and computational tools will be used to identify trends in metabolite production at sampling
sites with and without eelgrass and support biological assays (Aim 2) in prioritization of samples for further
investigation of new bioactive natural products. In Aim 2, a high-throughput magnetic microbead affinity selection
screening assay (MagMASS) will be used to identify ligands of GRP78 from the complex mixtures in sediment
extracts. When possible, hits identified in this assay will be verified using a cellular thermal shift assay to test
GRP78 binding in cells. Extracts will additionally be screened against a panel of bacterial and fungal pathogens
and bioactive components of complex mixtures will be predicted using computational methods (NPAnalyst). In
Aim 3, laboratory culturing of stabilized microbial communities from estuarine sediments and monocultures of
putative natural product producers will assist in linking natural products to their microbial producers and facilitate
resupply of prioritized natural products for comprehensive chemical characterization and advanced biological
testing.

Public health relevance
PROJECT NARRATIVE Estuaries are dynamic interfaces between the marine and terrestrial environments and estuarine sediments support a tremendous diversity of microorganisms which interact by expression of chemical signals or natural products. Microbial natural products have been valuable sources of therapeutic agents, and there remains a need for new biologically active compounds to study and treat drug-resistant cancers and infectious diseases. The use of in situ sampling methods paired with advanced mass spectrometric analysis will facilitate an unprecedented metabolomic study of estuarine sediment communities and identification of biologically active natural products with potential for human disease treatment and management.